SAFETY AND EFFICACY OF ZVD FOR ASYMPTOMATIC HIV INFECTED INDIVIDUALS

This study evaluates the safety and efficacy of ZDV at two dosages compared to placebo in long term administration to HIV infected asymptomatic individuals.